Statistics, computation and data sharing core

PROJECT SUMMARY Core C Core C, The Database, Computing and Statistics Core is central to the functions of the Program Project. It receives data from the Sequencing and Microbiome profiling Core and the Biochemical and Metabolic Services Core. An existing PPG database will be extended to receive the new data proposed for collection during the next cycle. There will be two sources of human and mouse data: the Hybrid Mouse Diversity Panel and the MetSim cohort of 10,000 men from Finland. These data will be cleaned, managed and maintained for the three PPG projects, and each will use data from both sources. Statistical genetics and genomic analyses will be designed, conducted and interpreted to satisfy the respective Specific Aims. The Core will interact with each projection a regular basis in order to conduct analyses in the most efficient and effective manner possible. It will be responsible for: 1) data storage, management and retrieval, 2) conducting or teaching project members to conduct routine statistical analyses such as comparing gene expression levels under different conditions, and 3) novel analyses that require study design, statistical analyses and interpretation of results. The Core will take responsibility for achieving compliance with any NIH policies regarding data submission to publicly available databases as the NIH rules evolve.

Public health relevance
PROJECT NARRATIVE Core C Core C will receive a large amount of data from the Cores and Projects and will manage the data in coordination with them. It will analyze and teach project members to analyze their data, as appropriate. It will design and conduct novel analyses and discuss and interpret results with those conducting the projects.